Preclinical and Translational Shared Resource

PRECLINICAL AND TRANSLATIONAL RESEARCH SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Translational Research Shared Resource has been reorganized to include athymic animal and
pharmacology services previously provided by the Athymic & Preclinical Therapeutics SR (see Shared
Resources Management). This resulted in the formation of the Preclinical & Translational Shared Resource
(PTSR). The primary role of the PTSR, is to enable, enhance, and coordinate bioanalytical study components of
clinical trials, and provide support for preclinical drug discovery efforts in the Case Comprehensive Cancer
Center (Case CCC). The Center-managed PTSR assists clinical investigators with conduct of preclinical animal
studies, logistics, processing, and analysis of biospecimens from Case CCC clinical trials, providing efficient and
cost-effective services that would otherwise not be available to individual investigators. This SR maintains sites
in proximity to patient treatment facilities at University Hospital (UH) Seidman Cancer Center (SCC) and the
Cleveland Clinic (CC). In addition, the Wolstein Research Building at Case Western Reserve University (CWRU)
houses the Preclinical Drug Testing Laboratory (PDTL) and facilities for additional bioanalytics.
In the current funding cycle, 234 investigators, 59% of whom were Case CCC members, accounting for 76% of
total usage, from all 6 of the Case CCC research programs utilized the SR. The Specific Aims of the PTSR are
to:
1. Provide Case CCC members with low cost immunodeficient mice, a library of PDX models, testing drug
anti-tumor efficacy, performing PK/PD studies in support of IND applications, training of Case CCC
member laboratories in animal techniques to facilitate technology transfer.
2. Provide assistance with design of bioanalytical studies associated with Case CCC clinical trials, to review
and oversee logistics for processing of biospecimens and provide centralized, professionally-coordinated
resource centers for logistics, processing and analysis of biospecimens.
3. Support preclinical drug development efforts by providing consultation in the design of drug development
projects utilizing new agents or combinations and performing in vitro and in vivo analyses of these agents.
This lab provides Cancer Center investigators with access to a variety of methods for the isolation of nucleic
acids from a wide variety of biospecimens from human clinical trial patients as well as numerous preclinical
models ranging from cultured cells to animal models.